EFFECT OF ANIMAL ASSISTED THERAPY ON ANXIETY IN ACUTELY ILL PATIENTS

This study tested the hypothesis that animal assisted therapy may be used as nursing intervention to reduce anxiety in acutely ill hospitalized patients. A pre-test post-test design was used to test the hypothesis with the Spielberger State-Train Anxiety Inventory employed to measure anxiety.